Quantitative 'Omics Core

ABSTRACT
The Quantitative `Omics Core (QOC) is being created to apply and develop innovative statistical and
bioinformatics tools to assist investigators in addressing precision medicine needs across a diverse range of
human diseases. The emerging field of precision medicine (PM) offers the possibility of improving the health of
patients through targeted treatments and therapeutics based on the unique characteristics of the individual.
Due to its short history as a field and its very nature, PM studies frequently require custom solutions and novel
statistical and bioinformatical methods. For the same reasons, it requires biostatisticians and bioinformaticians
with a cross-disciplinary, “team-science” background, to enable both a comprehensive understanding of the
needs of domain experts and the requisite technical expertise to support those needs with the application of
state-of-the-art biostatistics/bioinformatics techniques and methods, and when necessary, the development of
custom solutions. For many PM projects, generating the data marks only beginning of the challenge, with
analysis and interpretation representing a major bottleneck in translating raw data into clinically actionable
information.
The long-term objective of the QOC is to build and maintain an infrastructure that enables the application of
rigorous biostatistics and bioinformatics analyses with a measurable impact on the ability of COBRE
investigators to both publish their work and compete for R01-type funding. To achieve this objective and to
address the above challenges, the Core will leverage its expertise in study design, data management, data
visualization, bioinformatics, and the analysis and interpretation of high-throughput `omic studies, including
studies of gene expression (microarray and RNA-seq), pathway analysis, protein-DNA binding (e.g. ChIP-seq),
DNA methylation, DNA variation, and integrative multi-omic analysis. The QOC, directed by Devin Koestler,
PhD, consists of faculty and staff with a complimentary skill set in the areas of biostatistics, bioinformatics and
statistical `omics. The considerable overlap between these three areas allow COBRE investigators to work
with a single core for their data collection, management, analytics, bioinformatics, and statistical needs. In
addition, the synergy between the areas encompassing quantitative `omics allows the Core to provide a wide-
range of quality services to COBRE researchers in a timely fashion. The Core already has an impressive track
record in applying and developing innovative analytical strategies for cancer-related studies and will seek to
expand these successes into other disease states.